Integration of substance use and mental health services for justice-involved young women in Brazil

PROJECT ABSTRACT
The current proposal seeks to study implementation of integrated substance use and mental health services
for justice-involved young (JIY) women in Brazil. Despite a significant rise in rates of substance use disorders
among JIY women (age 18-24) globally the past decade, implementation of evidence-based substance use
services remains critically low in low- and middle-income countries (LMIC), and the global health field has
made minimal progress in rigorously examining factors governing their implementation. Co-occurrence of
substance use and psychiatric disorders among JIY women is the norm worldwide, with exposure to trauma
theorized as a mechanism underlying the onset and mutual maintenance of co-occurring symptoms. In LMIC
like Brazil, substance use services are delivered in isolated and minimally funded healthcare systems by
providers with low capacity to address simultaneous psychiatric symptoms and exposure to trauma that may
generate and maintain substance use. Contextually appropriate integration of substance use and mental health
services (i.e., concurrent provision of substance use and mental health services by one or a set of providers)
may be a viable means of increasing implementation of substance use services for JIY women in LMIC
settings. The proposed study leverages advances in substance use services research, implementation
science, juvenile justice, and global health to guide integration of Contingency Management (CM), a gold
standard substance use intervention, with brief cognitive behavioral therapy (CBT) services for JIY women re-
entering community from juvenile detention in Brazil. JIY women released from detention (age 18-22 years) are
a high-risk population with elevated rates of substance use relapse and high rates of co-occurring psychiatric
disorders and trauma exposure. Mixed-methods data will be used to explore individual- and provider-level
barriers and facilitators to integration of CM/CBT services for this population. An understanding of multi-level
implementation factors will inform development of a provider implementation plan in integrated CM/CBT
services delivery. A mixed-method open trial will examine preliminary feasibility and acceptability of integrated
services. The provider implementation plan will include trauma-informed considerations to enhance
implementation of substance use services. Study findings can be used to inform best practices for delivering
integrated substance use and mental health services for JIY adult populations in LMIC, as well as high-income
countries where implementation of integrated interventions significantly lags. Findings may also serve as an
important demonstration project in LMIC settings as they tackle the significant burden of young adult substance
use. The study benefits from well-established community collaborations in Brazil, a strong mentorship team,
and the F32 applicant’s prior global mental health research training to fulfill its aims.

Public health relevance
PROJECT NARRATIVE The rapid rise in untreated substance use among justice-involved young (JIY) women in low- and middle- income countries (LMIC) is a critical global public health issue and there is a pressing need to study implementation factors that hinder delivery of substance use services. Integrating substance use and mental health services is a potential efficient and sustainable means of closing the substance use treatment gap for JIY women, but there is limited research on how to effectively implement integrated services in LMIC. The current study leverages quantitative and qualitative methods to study multi-level implementation factors influencing integration of an evidence-based substance use intervention with existing mental health services for JIY women in Brazil, with the goal of informing best practices for services integration in LMIC and resource- constrained, high-income country settings.